Structured light temporal focusing depth-resolved wide-field FLIM-FRET for in vivo synaptic imaging

In spite of recent progress, our understanding of cognitive disorders remains tenuous. While outward
symptoms of neurodegenerative and mental disorders, ranging from Alzheimer’s to schizophrenia, are readily
apparent, their underlying cellular mechanisms are unclear. Most, if not all, exhibit some form of synaptic
dysfunction and/or circuit abnormality. Unfortunately, our ability to monitor disruptions in synapse or circuit
connectivity as they occur in vivo has been hindered by the difficulty of visualizing individual synaptic contacts
at sufficient resolution to discern their formation or elimination. The primary challenge for imaging synaptic
connections lies in the narrow cleft separation of 20-50 nm that is far below optical resolution. Here we propose
a new approach to identify synapse formation and dissociation in vivo by monitoring the distance between pre-
and post-synaptic protein pairs using fluorescence resonance energy transfer (FRET). In Specific aim 1 we will
develop wide-field depth-resolved FLIM-FRET by implementing De-scattering with Excitation Patterning (DEEP),
a wide-field depth resolved imaging approach based on structured light temporal focusing two-photon excitation
that we recently demonstrated is compatible with in vivo neural imaging. We propose implementing DEEP for
FLIM by using avalanche photodiode arrays with nanosecond gating to simultaneously resolve lifetimes with
over two thousand detectors. For testing microscope development, we will express in the mouse brain, in vivo,
known intramolecular FRET pairs using our previously developed methods for sparse, multi-fluorophore neuronal
labeling. In Specific aim 2 we will generate a series of FRET donor/acceptor molecules fused to variants of the
neuroligin-neurexin trans-synaptic partners in a variety of configurations, designed so that donor-acceptor
distance is kept within ~5 nm in the bound state for FRET to occur. These fusion constructs will be screened in
cultured neurons and selected based on faithful synaptic localization, lack of interference to normal synaptic
dynamics, and the presence of strong FRET signal upon fusion partner binding. The in vivo labeling strategy will
be a modification of one we recently developed for imaging Layer 2/3 pyramidal cell dendritic arbors and their
resident synapses in vivo using a three-color two-photon system, modified to avoid co-expression of donor and
acceptor in the same cell. The postsynaptic fusion protein will be co-expressed with a cell fill to visualize a single
targeted cell with all its postsynaptic sites. Where these sites contact labeled presynaptic terminals, transsynaptic
binding should place the fluorescent donor/acceptor pairs in close proximity, allowing FRET. Selected pairs will
then be tested in vivo in the brain for performance in the presence of autofluorescence and signal loss from
scattering in deep layers.

Public health relevance
Our ability to monitor disruptions in synapse formation and circuit connectivity in the brain, as they occur in vivo, has been hindered by the difficulty of visualizing individual synaptic contacts at sufficient resolution to discern their formation or elimination. Here we propose to develop a 3D resolved, high throughput, wide-field FLIM-FRET approach for monitoring of synapse assembly and disassembly throughput the neuronal arbor in vivo.